US-Cuba Administrative Supplement to the Viral Immunity and Vaccination (VIVA) Human Immunology Project Consortium

SUMMARY
Viral Immunity and Vaccination (VIVA) Human Immunology Project Consortium (HIPC) will carry out a
comprehensive program for assessing the dynamic human immune responses to vaccination. The VIVA HIPC
will leverage recent advances in human immune profiling methods to characterize the diverse states of the
human innate immune system before and after vaccination against these infectious diseases using novel
immune phenotyping and genomics strategies that generate data and tools to be used for downstream data
analysis and functional investigations. We will generate human immune profiles and signatures for vaccinations
against SARS-CoV-2 (Project 1), seasonal influenza (Project 2) and dengue viruses (Project 3). We will use
holistic approaches to provide cutting-edge standardized and qualified `omics' assays to assess cellular and
serological Immune responses to vaccinations, genomics/transcriptomics, including scRNAseq, CITEseq and
spatial tissue transcriptomics, and experimental vaccinations in primary human tonsillar histocultures in Projects
1, 2 and 3. We will perform data mining, bioinformatics analyses across data sets, and modeling for integration
of the `omics' datasets to identify the network components and infer their interactions and correlations important
for outcomes. The VIVA HIPC will make the data available for use by the research community and provide the
analyses and immune profiles generated to the scientific community. We will couple our local data infrastructure
to ImmPort to ensure full and timely release of clinical, sample, and experimental meta-data in synchrony with
genomic data releases to standard data repositories. The multi-disciplinary team of investigators with
complementary expertise in viral immunology, viral pathogenesis, vaccinology, genomics and data analysis, will
ensure the success of the VIVA program.

Public health relevance
Project Narrative The Viral Immunity and Vaccination (VIVA) team studies how to best generate protective immune responses to vaccination against viruses such as but not limited to SARS CoV-2, influenza and dengue viruses. We leverage the team's extensive expertise in virology, immunology, genomics and data analysis with cutting edge technologies to achieve these goals.